The role of IL-27 in sustaining the exhausted CD8 T cell response to persistent infection and cancer.

Project Summary
Chronic infection and cancer are associated with suppressed T cell responses resulting in the inability to control
these diseases. Over the last 15 years, blockade of negative immune regulators has proven effective in a small
number of cancer patients and shown promise in animal models of chronic viral infection. Despite these
encouraging results, no effective immune therapies exist for chronic viral infection and most patients fail to
respond or develop resistance to checkpoint blockade. Recent work identified memory-like CXCR5+ TCF1+ CD8+
T cells which sustain T cell responses during persistent infection and cancer. Importantly, these cells generate
the major proliferative burst observed following anti-PD1 treatment. Further, the numbers of TCF1+ CD8 T cells
in tumors correlate with favorable responses to anti-PD-1 treatment. As such, approaches to expand these cells
are actively sought.
We recently reported that blockade of interferon type 1 (IFN-I) receptor leads to expansion of CXCR5+
CD8+ T cells in an IL-27-dependent manner. IFNAR1 blockade promoted accelerated cell division and retention
of TCF1 in virus-specific exhausted CD8+ T cells. We found that CD8+ T cell-intrinsic IL-27 signaling promotes
the TCF1-high cells to maintain proliferation and avoid programmed cell death. Mechanistically, IL-27 endowed
rapidly dividing cells with IRF1, a transcription factor that was required for sustained division in a cell-intrinsic
manner. These findings revealed that IL-27 is essential for the expansion of TCF1+ CD8 T cells following
persistent viral infection. We hypothesize that IL-27 produced by specific cell subsets is necessary to
safeguard rapidly diving CD8 T cells from apoptotic cell death during both persistent viral infection and
cancer. We propose in this application to explore the basic biology of IL-27 signaling as it relates to CD8 T cell
expansion, survival and function. We will assess the cellular populations and signals that induce IL-27
production, assess how IL-27 prevents apoptosis of rapidly diving TCF1+ CD8 T cells and expand our exploration
into whether IL-27 signaling following anti-PD-1/L1 treatment during persistent LCMV infection and syngeneic
tumors is crucial for the CD8 T cell expansion/function. Once completed these studies will provide important
basic knowledge of how IL-27 regulates anti-viral and anti-tumor responses. Moreover, findings from this study
should point the way to treatments and modalities that can be employed to sustain optimal T cells responses.

Public health relevance
Project Narrative Identifying ways to improve CD8 T cell responses to viral and infection and cancer is a goal of immediate importance. We recently identified that the cytokine, IL-27, promotes expansion and CD8 T cell responses during persistent viral infection. In the current proposal we will investigate the cellular sources of IL-27, how this cytokine sustains CD8 T cells survival and whether IL-27 signaling is essential for sustaining CD8 T cell responses to anti-PD-1/L1 therapy during persistent viral infection and cancer; the ultimate goal of these studies is to understand how IL-27 promotes optimal CD8 T cell responses in these disease states.